Epigenetic mechanisms of carcinogenesis by Parvimonas micra, an oral cavity commensal turned colon cancer pathogen

Project Summary Abstract
Colorectal cancer (CRC) is among the most common malignancy worldwide and has a high mortality rate. In
spite of advances in our understanding of the genetics and immunology of CRC, it remains largely resistant to
therapy. Colonization of the large intestine by oral microbes is common among healthy individuals. Many of these
commensals have pathophysiological effects in CRC patients. However, their mechanism of action is unclear.
Our recent study identified Parvimonas micra as the most enriched oral bacteria in CRC patient stool and colon
mucosa relative to healthy individuals. Networks of P. micra and other oral commensal in the stool of CRC
patients excluded protective commensals. Changes in DNA methylation of a set of cardinal genes in the colon
mucosa and blood of the patients predicted CRC risk. Transfer of CRC stool to germ free mice that were treated
with AOM resulted in DNA methylation of the host and formation of aberrant crypt foci, over and above that
observed with transfer of microbiota from healthy individuals. We provided preliminary data that P. micra can
directly methylate human colon tumor cells when co-cultured together under hypoxic conditions. On the basis
of these findings we hypothesize that oral commensals exemplified by Parvimonas alter DNA methylation
of host DNA to adapt to tumors and promote CRC. We will address this in two Specific Aims. 1. We will test
the hypothesis that in mouse models of spontaneous CRC, P. micra alters DNA methylation and expression of
host genes that affect CRC tumor growth and tumor associate immunity. Mice prone to spontaneous CRC will
get healthy human microbiota with or without P. micra, or L. acidophilus for comparison. Reduced representation
bisulfite sequencing (RRBS), ATACseq, RNAseq, immune assays, and histopathology will determine how
changes in DNA methylation impacts, (1) the growth and invasion of CRC tumors, (2) tumor associated
inflammation and immune response, (3) microbial community composition of the tumor mucosa and stool. 2. We
will test the hypothesis that P. micra and bacterial community networks regulate tumor growth and immune
response in CRC by altering DNA methylation of host cells. To test this we will, (1) Identify clusters of fecal and
tissue-adherent bacteria in CRC patients and relate these to the DNA hypermethylation of patient colon and
blood across different CMS subclasses, (2) determine how altered DNA methylation of tumor and blood relate
to mutation load and immune response, (3) distinguish pathogenic versus protective patterns of DNA methylation
in colon epithelial organoids, that result from exposure to P. micra, versus L. acidophilus.

Public health relevance
Project Narrative Based on our recent findings we propose that oral commensals methylate host cell DNA, and in this process promote tumor growth and compromise immune responses. We will test this with microbiota humanized mouse models of colorectal cancer, and patient specimens including tumor organoids. \.